PTSC 2.0

Building on the current state of success of the AoURP, we recognize a need to enable maximum innovation and flexibility to enroll and retain one million or more diverse participants. Through data-driven strategies, technology solutions, open ecosystem and excellent service, PTSC can help increase efficiency of recruitment, return information and value to participants, increase retention and meet people where they are. Our PTSC 2.0 proposal combines the best of technology, people, and coordination to help the Program succeed. PTSC has been an integral part of innumerable planning sessions with AoURP Leadership working together with the Program Officer, Chief Technology and Chief Experience Officers, communications leads, HPO leads, and genomics lead to create the roadmap necessary for the Program to achieve its mission in the next several years. These interactions shaped the PTSC’s three key overarching themes: • Continuous improvement of existing technology systems and processes based on learnings • Expansion to meet growing needs of AoURP • Innovation to maximize new research strategies and technology solutions To accomplish these aims, the PTSC will operationalize the following five key values: • Openness: Promote, maintain and invite others to openly contribute data and technology to the AoURP • Service: Explicitly serve the program, its participants, and enrollment partners • Acceleration: We must move with haste to address the accelerating scientific needs of the program • Flexibility: Work to ensure that PTSC resources can be allocated responsibly where needed • Security: Continue to vigilantly maintain the rigorous privacy and security standards of the AoURP